Improving IVF Success through Multiplexed Optical Metabolic Imaging

Summary
In assisted reproductive technology (ART), morphological evaluation by bright- or dark-field optical microscopy
is the most critical assessment on the implantation potential (viability) of an in vitro fertilized embryo. Ideally the
obtained morphological information should be complemented with spatially resolved metabolic or functional
information. This would provide a more complete picture of the embryo itself and may thus offer a more
objective viability assay to increase the successful rate of an embryo transfer toward (singleton) live-birth.
Currently, fertility clinic providers are unable to visualize embryonic metabolism, whereas the spectroscopy-
based metabolic profiling under development has lacked spatial resolution. Therefore, a critical need exists to
superimpose spatially resolved metabolic information on morphological information for full assessment of the
embryo before implantation.
An interdisciplinary partnership composed of collaborating investigators in optical instrumentation, reproductive
biology, and computer science will address this critical need by multiplexed optical metabolic imaging (MOMI).
In contrast to the intrinsically label-free bright- or dark-field optical microscopy unable to obtain molecular
information and resolve a three–dimensional structure, MOMI enables these abilities via well-known
endogenous metabolites and nonlinear optical excitation, respectively, while critically retains the label-free
aspect required for potential clinical application. The preliminary results have demonstrated the utility of MOMI
as a general imaging assay for unlabeled live cells and cultured spheroids or organoids. This partnership will
thus aim to validate the MOMI in an established bovine model of ART. Future plans are to extend these
methodologies to improve human ART.
The goal of this partnership will be achieved through a systematic approach. First, the inclusion of fluorescence
lifetime imaging will upgrade MOMI to an omics-like assay, and a dedicated environment of incubation will be
built to interface the imaging with preimplantation embryo culturing. Also, an established bovine model for
human ART will be employed to image 2500 preimplantation embryos and track subsequent live births of
~1000 embryo transfers. Finally, a novel machine learning algorithm based on multi-cell graph neural network
from MOMI images will be developed to predict the viability of a preimplantation embryo (prospectively).
The successful completion of this project will validate MOMI as a safe live-cell imaging assay for non-ART
biomedical applications such as cell therapy and drug screening, considering the embryo development as a
well-known sensitive bioassay for plausible optical imaging-induced phototoxicity. More importantly, this large-
scale preclinical study will justify a randomized clinical trial for human ART. Ultimately, the clinical application
of MOMI may significantly improve the success rate of live births versus embryo transfers that has remained
stagnant in the last decade (35-37%) and may therefore reduce the associated pain and cost.

Public health relevance
Narrative Assisted reproductive technology has treated human infertility and increased livestock reproduction for decades but has been limited by a low success rate of ~40%. Multiplexed optical metabolic imaging (MOMI) can visualize subcellular resolution functional or metabolic information along with standard structural or morphological information in three dimensions free of labeling agents. This will allow the selection of most viable in vitro fertilized embryos via image-based machine learning and may thus lead to a higher success rate.